Alternative polyadenylation as a genetic regulatory mechanism to bridge genome to phenome in the nervous system

PROJECT SUMMARY
Anorexia nervosa is the deadliest psychological disorder with an estimated 10% lifetime disease mortality
rate, while over 1/3 of all cancer patients will die from disease-based anorexia, not the cancer itself. On the
opposite end of the spectrum, over 2/3 of US adults are overweight or obese, and this number, as well as the
rates of associated comorbidities such as heart disease, diabetes, and cancer, is only expected to increase in
the coming years. Despite the opposite directionality of these eating disorders, dysfunctional eating in obesity
and anorexia is mediated by common appetite circuitry in the central nervous system (CNS). Numerous studies
have documented a coordinated and complex pattern of changes in multiple gene products in these appetite
centers following periods of excessive or inadequate eating. These observations strongly suggest that the
behavioral decision to eat excessively or inadequately is likely driven by a multitargeted, maladaptive genetic
reprogramming process in CNS appetite centers. Thus, a core question is what global process could coordinate
such changes in multiple gene products? My published studies have demonstrated that appetite changes align
with changes in alternative polyadenylation (APA) in the hypothalamus. APA is a rapid, activity-dependent RNA
processing mechanism that regulates mRNA transcript stability, maturation, and localization. I identified a
significant APA pattern change on tissue inhibitor of metalloproteinases 2 (Timp2), a gene previously implicated
in the development of an obese phenotype. Thus, I am exploring the hypothesis that Timp2 APA in the arcuate
nucleus (ARC) of the hypothalamus meters the development of obesity. My proposed experiments in the F99
phase will show that 1) Timp2 mRNA is necessary for appetite control in the ARC, and that 2) APA regulation of
ARC Timp2 is necessary to counteract hyperphagia and obesity. These studies will be the first to functionally
link APA regulation to feeding behavior and will serve as the basis of further genome to behavioral phenome
studies in my independent career. My Sponsor, Dr. Gary Wayman, and Co-Sponsors, Drs. Suzanne Appleyard
and Emily Qualls-Creekmore, are established neuroscientists at Washington State University with expertise in
molecular neuroscience (Wayman) and ingestive behavior (Appleyard and Qualls-Creekmore). My proposed
Research and Training plan will strengthen my theoretical and technical understanding of neurogenetics. In the
pre-doctoral F99 phase, I will learn shRNA and CRISPR/SaCas9 vector design and validation strategies, cell
culture techniques, stereotaxic surgeries, and advanced metabolic analyses. In the postdoctoral K00 phase, I
will build upon these skills and learn to use genetic mouse models, multi-omics, advanced bioinformatics, and
AI computational models to map genome to phenome regulation. Overall, the proposed training will optimally
position me to start an independent research career at a leading neuroscience research institute and advance
our understanding of RNA regulation as a functional link between the genome and the behavioral phenome.

Public health relevance
PROJECT NARRATIVE Anorexia and obesity lie on seemingly opposite ends of the disordered eating spectrum, yet it is well established that these conditions share appetite circuitry that influence the behavioral decision to eat in excess or scarcity. Presently, the genetic mechanism that results in this stark phenotypic difference is not known. The goal of this F99/K00 proposal is to determine if alternative polyadenylation, a rapid activity-dependent RNA processing mechanism, functionally controls information flow from genome to phenome to meter the development of an obese phenotype, as this information has the potential to better inform treatments for disordered appetite.